GENETICALLY DETERMINED IMMUNODEFICIENCIES--ANALYSIS OF DEFECTS &THERAPIES (HUMAN

The purpose of this study is to define the cellular and molecular bases of the different human primary immunodeficiency disorders so that more effective therapy can be developed. The creation of bone marrow stem cell chimeras allows a unique opportunity to examine the cellular and molecular bases of human thymic education.